Modulation of Stress-Induced Anhedonia over the Menstrual Cycle: A Multi-Method Investigation of Stress and Reward Mechanisms

Project Summary/Abstract.
Major Depressive Disorder (MDD) is a debilitating clinical disorder that is associated with a host of deleterious
impacts on individuals and society, including marital dissolution, unemployment, low educational attainment,
and increased risk for suicide.46,47,76,77 Moreover, MDD disproportionately affects women; incidence of MDD is
doubled in women as compared to men, specifically during their childbearing years.2-3 As such, it is imperative
to test models elucidating the etiopathogenesis of women’s enhanced risk for MDD to expedite development of
optimal screening tools and interventions for MDD in women of reproductive age. Anhedonia, or the subjective
loss of reactivity to pleasurable stimuli, is a known deficit of MDD,4-7 and acute and chronic stressors have
been shown to dampen behavioral and neural reactivity to rewards18-21—a phenomenon referred to as stress-
induced anhedonia18 which has been linked to increased depressive symptoms.24,78 Women may be especially
susceptible to stress-induced anhedonia due to their hormonal profiles. Progesterone (P4) and estradiol (E2)
levels fluctuate over the course of the typical menstrual cycle and have opposing associations with both stress
and reward reactivity. Stress sensitivity is increased28 and reward sensitivity is decreased35 in the mid-luteal
phase of the cycle when P4 is high. However, both systems exhibit opposite effects in the late-follicular cycle
phase when E2 is high, such that stress sensitivity is decreased33 and reward sensitivity is enhanced.35 Thus,
while previous research suggests menstrual cycle phases and ovarian hormones impact stress reactivity and
reward responsivity separately, no study has yet examined whether stress-related decreases in reward
sensitivity vary as a function of hormone levels or menstrual cycle phase—which could reveal a candidate
mechanism to partially explain sex differences in MDD risk and which could be targeted in future screening and
intervention efforts for women of reproductive age. The current study leverages a repeated-measures design to
test the novel hypothesis that systems underlying stress-induced anhedonia are modulated by ovarian
hormones and cycle phases. Specifically, the current proposal aims to: 1) examine the effect of an acute social
stressor on the neural reward response, 2) compare stress-related reductions in the neural reward response
both in the late follicular and mid-luteal phases, 3) examine associations between hormone concentrations and
stress-related reductions in the reward response, and 4) examine whether the hypothesized effects are
moderated by individual differences in sensitivity to ovarian hormones as measured via ecological momentary
assessment of affective and somatic symptoms across the menstrual cycle. The training experiences gained
through this fellowship will prepare the applicant for an independent research career investigating endocrine
and neural markers of risk for mood and anxiety psychopathology.

Public health relevance
Project Narrative. Major Depressive Disorder (MDD), a condition associated with low educational attainment,47 marital disruption,77 unemployment,76 and suicide,46 is a major public health concern that disproportionately affects women, as incidence of MDD is doubled in women as compared to men.2-3 Recent research suggests that ovarian hormones that fluctuate over the menstrual cycle impact stress28,33 and reward32,35 systems—systems that have been shown to interact to confer risk for MDD.18 The proposed research and training grant will test a novel hypothesis wherein specific ovarian hormones modulate the impact of stress on reward system functioning—a model that could help account for sex differences in MDD and aid in the future development of neurobiologically informed screenings and interventions for MDD in women of reproductive age.